Global analysis of the supraspinal connectome after spinal cord injury

PROJECT SUMMARY
The supraspinal connectome refers to the full set of neurons that reside in the brain and project axons to the
spinal cord. The sheer complexity of this connectome, both anatomical and functional, has presented stubborn
challenges to understanding and treating the highly variable disruption that accompanies spinal injury.
Anatomically, the wide distribution of the cell bodies has made it very difficult to trace and quantify all populations
simultaneously, leading most studies to focus on just one or several main supraspinal cell types. Functionally,
descending control is distributed across multiple populations with outputs that can be complementary,
antagonistic, or potentially compensatory after injury. These functional relationships strongly affect outcomes
after spinal injury but are difficult to capture in single- or several-tract approaches. This project aims to advance
the field though an approach that yields a comprehensive understanding of spinal injury at a whole-connectome
level and by providing new viral tools to selectively manipulate subtypes of brain-spinal neurons. First, we will
use 3D whole-brain and -spinal imaging to visualize and precisely quantify the number and activity level of spared
neurons in all supraspinal cell types across cohorts of animals that receive graded contusion injuries, while
simultaneously measuring both spontaneous and rehabilitation-induced recovery of function. With whole-brain
data and advanced statistical techniques we can take advantage of the natural variability between individual
animals to identify the elements of the connectome that are most predictive of recovery. Next, we will
systematically test these predicted functional relationships by targeted, reversible chemogenetic silencing of
selected supraspinal populations before injury, after injury, and after rehabilitation. Importantly, these silencing
experiments will employ both direct targeting of brain regions and newly developed viral tools that enable
selective manipulation of defined subtypes of spinally projecting neurons. Collectively, these connectome-level
data and new subtype-specific tools are needed to 1) help resolve lurking variability that currently challenges the
field, 2) provide a comprehensive, rational framework that prioritizes interest in the full sets of supraspinal
populations of highest relevance to functional recovery, and 3) provide a pipeline and data resources that extracts
maximal, brain-wide information from pre-clinical models of spinal injury to more fully align them with the complex
needs of individuals living with SCI.

Public health relevance
PROJECT NARRATIVE A major challenge to treating spinal cord injury and maximizing functional recovery is the sheer number of neural populations that carry brain-spinal information. To move beyond a tract-by-tract approach, this project harnesses new technology to survey the entirety of the affected cell types and then selectively manipulate genetically defined subsets, which will yield new insights into the injury and direct attention toward the most important sets of cells.